Administrative Supplement for ASIC design project

SUMMARY
Under an active Phase II proposal, Neural Dynamics Technologies Inc. will develop customizable,
high-density probes with integrated closed-loop capabilities that can be chronically implanted for
use in animals that are either head-fixed or able to move around freely. The first aim of our Phase
II proposal is to integrate light delivery and electrical stimulation capabilities onto our probes to
enable closed-loop experimentation. The locations for light delivery and electrical stimulation will
be customizable so that customers can specify their desired location. The second aim will be to
develop a packaging approach that involves building an application specific integrated circuit
(ASIC) and associated hardware that can control all integrated functionalities. This ASIC will be
developed in partnership with a dedicated integrated circuit design firm and semiconductor
foundry. The combined packaged device will be small enough to enable chronic experiments in
either head-fixed or freely moving animals. In this administrative supplement we are requesting
additional budget to cover the cost of creating this ASIC. In partnership with a carefully chosen
and US based ASIC design firm, NDT will design innovative closed-loop interfaces that will enable
causal studies addressing the functional role of different brain regions and neuron types in the
brains of both head-fixed and freely moving animals. These types of closed-loop devices may be
further evolved into neural implants to treat neurological diseases such as refractory epilepsy,
Parkinson’s and other tremor disorders.

Public health relevance
NARRATIVE Neurological disease will be a leading cause of chronic disease in the coming decades and to confront this development with effective therapeutics, we need a better understanding of the neural circuit activity that underlies both healthy and diseased brain function. To study the dynamics of neural circuit activity, technologies are required that can chronically measure the spiking activity of many individual neurons in vivo, in intact brains. Neural Dynamics Technologies develops innovative high-density implantable neural interfaces that can be customized to the morphology of different brain regions, and that offer integrated stimulation capabilities, therefore enabling causal, closed-loop and chronic recording of neural circuit activity.